JHU TRAC: Training and Supporting the Next Generation of TB Researchers

ABSTRACT — JHU TRAC OVERALL
Tuberculosis (TB) remains a major global health problem, and advances in the basic and clinical sciences are
urgently needed to make progress towards the World Health Organization’s End TB Strategy goal of reducing TB
deaths by 95% and new cases by 90% between 2015 and 2035. The Johns Hopkins University (JHU) Center for
Tuberculosis Research (CTR) has been a global leader in TB pathogenesis, translational models, diagnostics, drug
development, pharmacology, public health interventions, and epidemiological and economic modeling for more than
two decades. Research emanating from the CTR and JHU has transformed the treatment of TB infection and
disease, elucidated interactions between TB and HIV drugs, validated the efficacy and effectiveness of new
diagnostic tools, and contributed to the development of evidence-based policies for global TB control, based on the
epidemiology and population dynamics of TB. However, to make further progress in efforts to achieve the END TB
goals, additional innovative, cross-disciplinary and impactful research is critical and a new generation of TB
scientists must be recruited and trained, particularly among groups nationally underrepresented in health-related
research (UHRR). We have assembled a multidisciplinary team of researchers from multiple departments spanning
four JHU schools (Medicine, Public Health, Nursing and Engineering), with complementary expertise in microbial
pathogenesis, immunology, animal models, imaging, clinical trials, diagnostics, epidemiology, pharmacology and
pharmacometrics, computational modeling, and biostatistics, in order to provide added value to the TB research
enterprise at JHU optimize training opportunities for junior investigators and support for new, interdisciplinary
collaborations, with the goal of addressing key knowledge gaps in TB research. The JHU TRAC team comprises
58 researchers, including 32 experienced TB researchers (19 current members of the CTR), 15 senior researchers
new to the TB field, and 11 Early Stage Investigators (ESI). The overarching mission of the JHU TRAC is to advance
TB research by promoting innovative, multidisciplinary collaborations and by recruiting, training and supporting
junior Investigators, especially among UHRR groups, to develop the next generation of leaders in TB research. To
this end, the JHU TRAC will focus on these four areas: 1) Enhance the integration, productivity and impact of JHU
TB research; 2) Provide mentoring, support, and pilot funding for the next generation of TB researchers, and to
increase the pipeline of junior investigators from UHRR groups; 3) Support TB researchers with direct services from
a Clinical Core and three Scientific Cores; 4) Contribute to the END TB goals through global engagement, training,
outreach, and collaboration with partners in high-burden countries. The JHU TRAC is organized into six Cores
(Adminsitrative Core (AC); Developmental Core (DC); Clinical Core (CC); Microbiology, Immunology, Animal
Modeling and Imaging (MIAMI) Core; Pharmacology and Pharmacometrics Core (PPC); and Bioinformatics,
Modeling and Biostatistics Core (BMBC), which will interact closely with each other to promote synergy in TB
research, and ensure that the utility and output of the JHU TRAC is greater than the sum of its parts.

Public health relevance
NARRATIVE — JHU TRAC OVERALL To make further progress in efforts to achieve the World Health Organization’s END TB goals, additional innovative, cross-disciplinary and impactful research is critical and a new generation of TB scientists must be recruited and trained. The Johns Hopkins University (JHU) TB Research Advancement Center (TRAC) will provide added value to TB researchers at JHU by bringing together highly experienced researchers across multiple disciplines and representing four JHU schools (Medicine, Public Health, Nursing and Engineering) in order to optimize training opportunities for junior investigators and support for new, interdisciplinary collaborations, with the goal of addressing critical knowledge gaps in TB research.